MECHANISM OF BCL-X EXPRESSION IN LYMPHOCYTES AND CANCER

DESCRIPTION (Adapted from Investigator's abstract): Programmed cell death or apoptosis is a cellular suicide process that is necessary to maintain homeostasis in multicellular organisms. In recent years several genes have been cloned that function to either induce or inhibit apoptosis. Many of these genes share homology with the anti-apoptotic oncogene bcl-2. One of these genes, bcl-xL, can function in a similar fashion as bcl-2, yet displays a different pattern of expression. Specifically in lymphocytes Bcl-2 is expressed at high levels regardless of the activation state of the cell while Bcl-xL is expressed only upon cell activation. In addition, upregulation of bcl-x but not bcl-2 occurs in tumor cells following irradiation or induction of multidrug resistance. The objectives of this proposal are to determine the molecular mechanisms by which bcl-x expression is regulated. Specifically to characterize the bcl-x promoter and determine the cis elements which are involved in regulation of gene expression during lymphocyte activation as well induction of drug resistance in tumor cells. A fragment of genomic DNA which extends 2.7 kb 5' of the start methionine has been isolated. This fragment has two putative TATA boxes within 1 kb of the start ATG. The first specific aim is to determine usage of these TATA boxes by primer extension analysis and RNase protection analysis. Functional analysis will be carried out by subcloning promoter fragments into reporter constructs and determining regions of the promoter required for responsiveness to different activation signals. In addition, the cloned fragment contains a GC rich region that displays differential methylation in drug sensitive and drug resistant cell lines. The final aim of this proposal is to determine the methylation pattern of the bcl-x CpG island by sequencing of sodium bisulfite-treated DNA to reveal methylation sites. The role of methylation of the CpG island on bcl-x expression will be determined by in vitro methylation of reporter constructs. While bcl-x overexpression has not been shown to lead to any specific tumors, it's expression has been demonstrated in several types of tumors including breast, prostrate and the Reed-Sternberg cells of Hodgkin's lymphoma. Understanding the mechanisms by which bcl-x is controlled may result in the development of ways to increase the efficacy of cancer chemotherapy through decreasing the apoptotic threshold of the tumor cell. In addition determination of the methylation state of bcl-x in tumors may be a good indicator of the outcome of cancer chemotherapy of a given tumor.